AIM-AHEAD Coordinating Center - All Four Cores

The AIM-AHEAD Coordinating Center (ACC) establishes a consortium of institutions and organizations from a wide range of stakeholders (academic institutions, community organizations, private businesses, non-profits, and healthcare organizations) across the nation. The ACC focuses on coordination, assessment, planning, and capacity building to foster the development of AI talents and technology while strengthening the AI capabilities of institutions and organizations that otherwise lack the resources to pursue AI/ML innovations. The ACC comprises 4 key cores to drive this mission: 1) Leadership/Administrative Core: Lead the overall ACC, recruit and coordinate consortium members, project management, partnerships, stakeholder engagement, and outreach to develop AI/ML talented researchers in health research, and to establish trusted relationships with key stakeholders to support cutting-edge AI research. 2) Data and Research Core: Determine and address research priorities and needs in linking and preparing multiple sources and types of research data to form an inclusive basis for AI/ML use cases that will illuminate strategies and approaches to address chronic diseases. 3) Infrastructure Core: Coordinate, centralized, federated computing infrastructure that enhances the interoperability of large-scale data resources with data that are maintained, governed, and prepared by individual institutions to preserve privacy and autonomy. 4) Data Science Training Core: Assess, develop, and implement an AI and data science training curriculum and mentorship to increase the workforce in AI/ML analytics.

Public health relevance
No Public Health Relevance Available